A novel CRISPR/Cas12 system targeting HBV DNA for gene therapy

A novel CRISPR/Cas12 system targeting HBV DNA for gene therapy
SUMMARY
Approximately 250 million people are chronically infected with hepatitis B virus (HBV) worldwide. In the United
States, HBV infection remains a major public health problem. Current antiretroviral therapy using nucleotides
analogs (NA) can restrict HBV replication, however, the treatment cannot eliminate the viral DNAs that are integrated
into the host genome and cccDNA that is resistant to the current treatment. As such, HBV persist in NA-controlled
individuals, and NA cessation readily leads to viral reactivation and disease progression. Therefore, there is an
urgent medical need to develop a curative strategy that can eliminate the HBV (ccc)DNA without causing collateral
cytotoxic effects. While the CRISPR/Cas9 system has been widely used for genome editing, recent studies indicated
that a single guide RNA (gRNA) in the CRISPR/Cas9 system cannot completely inactivate the viral DNA, resulting
in viral escape. The new RNA-guided endonuclease CRISPR/Cas12 (formerly Cpf1) system is a more promising
tool for viral DNA engineering, with increased antiviral activity and specificity. A recent study compared Cas9 and
Cas12 systems for editing of the viral DNA and revealed superior antiviral activity for Cas12, which could achieve
full viral inactivation with only a single gRNA. Nevertheless, the current CRISPR/Cas12 delivery technologies often
require viral vectors, which pose safety concerns for therapeutic applications in humans. Synthetic gRNA/Cas12
ribonucleoprotein (RNP) is an attractive non-viral formulation for the CRISPR/Cas12 system due to its rapid DNA
cleavage activity, less off-target effects, low risk of insertional mutagenesis, easy production, and readiness for
clinical application. To date, whether synthetic gRNA/Cas12 RNP can be used to edit integrated HBV DNA and its
typical signature on the viral and host genomes remain largely unknown. Of note, highly potent and specific gRNAs
targeting critical HBV DNA site(s), and the efficacy of gRNA/Cas12 RNP in inactivating viral DNA replication have
yet to be evaluated. In this application, we propose to develop a novel synthetic CRISPR/Cas12 system targeting
HBV DNA and evaluate its antiviral activity and cytotoxicity using HBV cellular models. We hypothesize that synthetic
gRNA/Cas12 RNP will abolish HBV replication efficiently and will elicit minimal cytotoxic effects. We propose two
specific aims to test our hypothesis. Aim 1 will design/synthesize a series of HBV gRNA/Cas12 RNPs and test their
antiviral activity in HBV cellular models. Aim 2 will evaluate off-target effects and cytotoxicity of these HBV
gRNA/Cas12 RNP in these cellular models. The goal of this project is to generate a proof of concept, collect key
data, establish a new technology, and lay the foundation to achieve our long-term goal of developing an HBV
cure. Our preliminary studies, experienced investigators, novel approach, and excellent environment ensure the
likelihood of completing this clinically significant study in a timely manner. This research supplement will support an
unrepresentative graduate student’s training and add diversity profile of PI’s research workforce.

Public health relevance
NARRATIVE Without advancement in new therapeutics, patients with HBV infection are subject to lifelong treatment. Thus, multimodal, robust pharmaceutical strategies are desperately needed to eliminate HBV (ccc)DNAs, which is considered the cornerstone of HBV cure. In this study, we will test the efficacy and cytotoxicity of synthetic gRNA/Cas12 RNP targeting HBV DNA using cellular HBV models. If successful, this translational research will provide a novel technology platform that may be used in combatting HBV infection, but also other emerging viral diseases. It is thus clinically significant and timely.